Targeted Awareness and Education on Options in Uterine Fibroids

PROJECT SUMMARY – PROJECT 1
Non-Hispanic Black, African American (BAA) women have a 2 to 3 times higher uterine fibroid incidence rate
compared to non-Hispanic White women. BAA women report experiencing higher disease burdens compared
to non-Hispanic White women, including longer symptom duration and lower health related quality of life. They
also report earlier onset of symptoms, and substantial delays in seeking care for fibroids. These delays may be
due in part to historical data showing that BAA women undergo more hysterectomies compared to other
populations, even when fertility preservation is a stated goal of patient care.
The benefits of early detection and treatment are myriad. Yet, such benefits go unrealized if women and girls
do not recognize the signs and symptoms of fibroids and communicate with health care teams to receive useful
information and self-care tools.
This proposal will use qualitative, community-based research to understand the experiences of women with
symptomatic fibroids. In turn, tactics will be developed using behavioral and social science research (BSSR)
methods—focused on increasing early awareness of signs and symptoms of fibroids—to increase knowledge
surrounding the range of treatment options.
Teams comprised of researchers at Mayo Clinic, the University of Florida, and the University of Mississippi
Medical Center will work together to engage patients in their local areas and develop culturally appropriate
education and dissemination.